A comprehensive prognostic model for older adults discharged to skilled nursing facilities.

PROJECT SUMMARY/ABSTRACT
An estimated 20% of hospitalized older adults were discharged to a skilled nursing facility (SNF) in 2019 with
many subsequently experiencing potentially adverse outcomes, including hospital re-admission, entering long-
term care (LTC) rather than returning to the community, and death within 6 months. During this critical
transition period following a hospitalization, clinicians, patients, and families often have discordant expectations
about the trajectory of the SNF stay which can lead to dissatisfaction with care and disagreements over care
plans. For SNF clinicians managing these patients, decision making around management of acute and chronic
conditions, treatment preferences, and advance care planning is hindered by a lack of accurate prognostic
information. Providing individualized risk estimates for a variety of outcomes following SNF admission can help
frame these important discussions and facilitate shared decision making. Given that there are no widely used
prognostic tools for older adults specifically discharged to a SNF, the objective of this study is to develop an
easy-to-use and parsimonious prediction model that jointly models multiple outcomes. A 20% sample of
community-dwelling Medicare beneficiaries aged 65 years and older discharged from a hospital to a SNF will
be used to investigate two specific aims: (1) develop and internally validate a Day 1 prognostic model to be
used on day 1 of SNF admission that provides risk estimates of multiple outcomes including hospital re-
admission, discharge home without readmission, prolonged SNF stay >100 days (suggesting transition to
LTC), and 6-month mortality and (2) develop an Updated model which provides refined estimates using
detailed information from the Minimum Data Set (MDS) assessment that may not be readily available or widely
collected by clinicians on day 1 of SNF admission. The result of these aims will be 2 easy-to-use parsimonious
models that can provide accurate and well calibrated estimates of outcomes following a SNF admission.
Significance and Innovation: Results from the proposed research project will directly inform clinical practice by
allowing SNF clinicians to input specific patient characteristics into a web calculator to obtain risk estimates for
multiple outcomes that can frame conversations with patients and families around clinical management
decisions and future planning. This project is innovative because it will be the first SNF outcome prediction
model to predict multiple clinically relevant outcomes simultaneously using a minimal number of variables that
can be easily implemented in clinical practice. Future directions of this work will involve investigating more
advanced modeling techniques, such as dynamic predictions and multi-state modeling, and ultimately explore
how providing this prognostic information can improve satisfaction with care and other patient-centered
outcomes in a randomized clinical trial.

Public health relevance
PROJECT NARRATIVE Community-dwelling older adults admitted to a skilled nursing facility (SNF) following a hospitalization represent a medically complex and vulnerable population at high risk for several potentially adverse outcomes. This project uses a sample of Medicare beneficiaries aged 65 years and older discharged from a hospital to a SNF to develop and internally validate a parsimonious clinical prediction model for multiple separate outcomes (hospital re-admission, successful discharge home, prolonged SNF stay suggesting transition to long-term care, and 6-month mortality) using readily available clinical predictors that will allow SNF clinicians to directly obtain risk estimates through an easy-to-use web calculator. Prognostic information from this calculator can help frame conversations with patients and families related to management of acute and chronic conditions, treatment preferences, and future planning, and will lay the foundation for future work exploring how the implementation of this prognostic information can improve shared decision making and patient-oriented outcomes.